BLRD Research Career Scientist Award Application

AIMS: The goal of this application is to competitively renew Dr. Jian-Ying Wang’s Senior Research Career
Scientist Award and to continuously support Dr. Wang’s VA research program.
NOMINEE: Dr. Wang has held the position of Senior Research Career Scientist at Baltimore VA Medical
Center (BVAMC) since 2011; and held a faculty position as professor (with tenure) at University of Maryland
School of Medicine since 2002. Dr. Wang is widely acknowledged for his groundbreaking work identifying
novel long noncoding RNAs (lncRNAs) and RNA-binding proteins (RBPs) in the intestinal epithelium
homeostasis under various pathophysiological conditions. Dr. Wang has published >190 peer-reviewed
original research articles which have created ~11,000 total citations, and his research program has been
continuously supported by VA Merit Review Awards and multiple National Institute of Health-R01 grants for
more than twenty-eight years. Dr. Wang is a successful mentor/sponsor for VA Career Development Awards
and acts as a co-investigator on several current VA sponsored research projects.
RESEARCH: Studies in Dr. Wang’s laboratory define the fundamental mechanisms underlying injury-induced
intestinal epithelial regeneration and gut permeability; as well as studying new and effective therapies to
enhance repair of damaged mucosa and preserve the intestinal epithelial integrity in patients with critical
illness. Dr. Wang’s research program addresses an important clinical issue that is highly relevant to VA
healthcare. Intestinal mucosal inflammatory injury/erosions and delayed healing occur commonly in our
Veteran population, such as patients who suffer from Crohn’s disease/ulcerative colitis, peptic/stress ulcers,
and critical surgical disorders: trauma, sepsis, shock, and massive surgical operations. Persistently impaired
integrity of the intestinal epithelium from diffusive mucosal injury/erosions and delayed healing leads to the
translocation of luminal toxic substances and bacteria to the bloodstream and, in some instances, multiple
organ dysfunction syndrome and death. Effective therapies to preserve the integrity of the intestinal epithelium
and enhance recovery of damaged mucosa are limited, because of poorly understood mechanisms underlying
gut mucosal disruption. Dr. Wang’s group has applied state of the art molecular and RNA approaches to
complex cell biological systems and human gut mucosal diseases. Approaches that examine specific lncRNAs
and mRNAs including approaches focused on large-scale RNA analyses are regularly employed in his lab.
Dr. Wang’s group has extensively applied tissue-specific gain-of-function transgenic and knockout approaches
to generate various genetically modified animal models. These approaches and experience have provided
Dr. Wang with an appreciation for the study mucosal tissue and cells directly and to move back and forth from
human disease to model systems and to validate key findings in the human context. The overarching goals of
Dr. Wang’s research program are to define cellular and molecular processes that govern gut mucosal
protection, injury-induced epithelial regeneration, and barrier function; additionally studying lncRNAs and RBPs
as novel therapeutic targets for intervention to improve mucosal repair after acute injury and to protect the gut
barrier integrity in patients with critical illness.
IMPACT: Dr. Wang’s research program elucidates novel roles of lncRNAs and RBPs in intestinal mucosal
regeneration and adaptation and addresses an important health issue in our veteran healthcare. Dr. Wang’s
work provides new insight to the development of improved therapeutics for treating patients with massive
intestinal mucosal injury/erosions and gut barrier dysfunction. Dr. Wang also actively collaborates with a
number of investigators in the BVAMC Research Service. His expertise and academic activity keep moving the
BVAMC research program forward.

Public health relevance
Dr. Jian-Ying Wang is a Senior Research Career Scientist, and his research program directly addresses an important health issue relevant to VA healthcare. Studies ongoing in Dr. Wang’s lab are part of his long-term goal: to fully investigate the mechanisms underlying impaired repair of damaged intestinal mucosa and gut barrier dysfunction, by searching for new therapies to maintain intestinal epithelial integrity in patients with critical illness. Mucosal injury-related disorders and gut barrier dysfunction occur commonly in Veteran patients, often those suffering from stress/peptic ulcerations, Crohn’s disease/ulcerative colitis, trauma, and sepsis. However, effective therapies are still quite limited in clinic. Because improved understanding of the mechanisms involved in mucosal disruption is the first step towards therapeutic initiatives, Dr. Wang’s research program will continue to promote development of more effective therapeutics targeting protection of the intestinal epithelium and recovery enhancement of damaged mucosa in VA patients.